Novel Protein Engineered Drug Conjugates Targeting Phosphatidylserine for the Treatment of Breast Cancer

7. Project Summary/Abstract
There remains an urgent, and largely unmet need for the advancement of highly selective and effective
therapeutic agents for the treatment of metastatic and triple negative breast cancer. This proposal advances an
innovative and promising strategy focused on the first time synthesis and evaluation of betabody-drug conjugates
(BDCs), which feature engineered proteins (referred to as betabodies) that target phosphatidylserine (PS). PS
is selectively exposed on the outer leaflet of the plasma membrane of cancer cells and endothelial cells in the
tumor microenvironment, but is confined to the inner leaflet of the plasma membrane of normal cells. This
provides an exquisite opportunity for selective targeting of potent small-molecule anticancer payloads (KGP18
and KGP156) to the tumor microenvironment. Betabodies are smaller allowing for better tumor penetration
compared with previously evaluated PS-selective antibodies, which demonstrated poor distribution beyond the
vasculature. BDCs are designed to selectively release KGP18 and KGP156 extracellularly by enzymes
(cathepsin B, urokinase-type plasminogen activator, and plasmin) that are upregulated and/or demonstrate
enhanced activity by breast cancer cells and associated tumor vasculature. KGP18 and KGP156 are potent
inhibitors of tubulin polymerization and demonstrate dual mechanism of action functioning as remarkably active
antiproliferative agents (cytotoxicity in low nM to pM range) and as profoundly effective vascular disrupting
agents, which impart irreversible damage to tumor-associated vasculature ultimately leading to tumor necrosis.
These synthetic benzosuberene-based payloads (KGP18 and KGP156) will be evaluated in comparative studies
to monomethyl-auristatin E (MMAE), which is a payload of choice in many clinically relevant antibody-drug
conjugates. It should be noted that VDAs are mechanistically distinct from the well-studied angiogenesis
inhibiting agents. Two individual delivery strategies will be investigated. KGP18 and KGP156 will be synthetically
functionalized with distinct, protease-selective peptide-based linkers rendering the drug-linker prodrug constructs
biologically inert until cleaved by specific proteases that are present at high levels in the tumor microenvironment,
thus selectively releasing the potent payload (KGP18 or KGP156). In a second strategy, BDCs will be prepared
from the best drug-protease selective linker constructs. The hypothesis is that appropriately designed drug-linker
constructs and their corresponding BDCs tethered to these highly potent payloads (KGP18 or KGP156) will
demonstrate high selectivity for tumor vasculature and tumor cells. Pharmacokinetic studies will evaluate the
release of the effector drugs from their corresponding constructs and conjugates. The efficacy and selectivity of
these drug-linker constructs and BDCs will be evaluated using cell-based studies and established murine
orthotopic breast cancer models (MDA-MB-231 human xenografts and syngeneic 4T1 tumors). In summary, it is
expected that each strategy will result in tumor-specific drug delivery and potent anti-tumor activity.

Public health relevance
8. Project Narrative The benefits derived from anticancer therapeutic modalities that are highly selective for tumors and/or the tumor microenvironment and effectively retard cancer growth serve as inspiration, catalyst, and challenge for accelerated research efforts in drug discovery and development. Highly potent, small-molecule anticancer agents (identified from a focused synthetic library of benzosuberene analogues) that effectively destroy tumor vasculature and separately interfere with tumor cell division, are targeted for selective delivery through drug- linker constructs and separately as highly innovative betabody-drug conjugates (BDCs), employing an engineered protein (betabody) that binds to a unique component of tumor vasculature and breast cancer cells. The relevance of targeted therapeutics rests in their potential to dramatically improve anticancer efficacy in patients while mitigating toxicity and adverse side-effect profiles.